The UCSC Genome Browser

ABSTRACT
The UCSC Genome Browser and associated tools are used by hundreds of thousands of biomedical
researchers including clinical geneticists, bioinformaticians, researchers working with model organisms, and
wet lab scientists researching human physiology at the molecular level in both healthy and disease states. The
browser integrates the results of thousands of biomedical labs – including a wide range of biochemical assays,
genetic studies, curations, sequencing projects, and computer analyses into a series of tracks aligned to the
underlying genomic sequence. The genome provides a natural integration framework for these diverse data
sources, which the browser showcases at a variety of display scales ranging from the single base to individual
genes, entire chromosomes, and ultimately to the genome as a whole.
The Genome Browser is implemented using robust, fast, high-quality software capable of handling over one
million hits per day. This web software provides a window into an exceptionally detailed and well-documented
database that can be queried computationally as well as browsed graphically. The database is loaded with a
suite of programs, developed both at UCSC and elsewhere, capable of distilling huge genomics data sets into
high-quality annotations of the genome. Significant engineering effort is invested to ensure the quality of the
software and data sets, including those developed by external contributors. The system is designed to make it
easy for users to view their own, unpublished, data sets alongside those that we have fully curated and
integrated. Consortia and other resources can make their data visible in our browser via “track hubs.”
We plan to extend our resources in significant ways. We will help make genomics cover a larger share of the
genetic variants in the US population by moving to a “pangenome” reference. We will enable visualization of
individual genomes, not just a single haploid reference genome. We will address the opportunities and
challenges of new technologies such as single-cell RNA sequencing and single-molecule long-read DNA
sequencing. We will collaborate with others in the increasingly complex ecosystem of biomedical consortia and
resources, and will integrate their results into the Genome Browser, and also, through our APIs and our helpful
staff, ensure that others can make the best use of data available in their efforts. We will provide tools and data
for medical users to understand the significance of sequence variants in the patients they care for and will help
characterize regions of greater genomic complexity and medical importance. We will extend our outreach effort
to include more online content to help engage a new generation of users

Public health relevance
PROJECT NARRATIVE The UCSC Genome Browser (https://genome.ucsc.edu) brings together many sources of information to help researchers and doctors understand the function of genes and other regions of the human genome. The Browser helps researchers intelligently design therapies for a broad range of diseases. For diseases caused by genetic variation, it helps doctors understand which variations cause which diseases.